Animal Research Support

The Comparative Medicine Branch (CMB) supports 155 active animal research projects for 62 active scientists in the Division of Intramural Research as well as the Division of the National Toxicology Program. A daily inventory of approximately 50 thousand rodents is maintained. The Branch ensures that all animal use is performed humanely and in accordance with all Public Health Service policies and federal guidelines. The NIEHS has maintained full accreditation by the Association for Assessment and Accreditation of Laboratory Animal Care International(AAALAC), an internationally recognized independent program, since 1972